Pennsylvania Occupational Safety and Health Surveillance Program (PennOSHS)

Project Summary/Abstract
Pennsylvania is the 5th largest state in the United States and has more than 6.1 million workers in a wide
range of industries such as education and health services, manufacturing, wholesale and retail trade, leisure
and hospitality, and mining and construction. As of 2018, Pennsylvania had 135,400 cases of nonfatal work-
related injuries and illnesses, the 4th highest number among the 41 states participating in the Bureau of Labor
Statistics (BLS) Survey of Occupational Injuries and Illnesses (SOII). Occupational blood lead poisoning has
been a major concern in Pennsylvania and case counts rank among the highest in the nation. A
comprehensive, state-wide occupational health surveillance program needed to address the burden of work-
related morbidity and mortality is non-existent in Pennsylvania. As part of its mission to promote healthy
behaviors and prevent injury and disease among its residents, the Pennsylvania Department of Health (PA DOH)
proposes to establish a fundamental Occupational Safety and Health Surveillance (PennOSHS) program. The
program seeks to build sustainable public health infrastructure in Pennsylvania to reduce occupational
morbidity and mortality and eliminate occupational health disparities that contribute to overall health disparities.
PennOSHS aims to (1) collect, compile, and analyze occupational health data to identify areas that require
targeted actions by public health practitioners and other stakeholders and (2) disseminate relevant information
to these stakeholders to improve health outcomes. Specifically, PennOSHS will develop, analyze and interpret
the National Institute for Occupational Safety and Health (NIOSH)/Council of State and Territorial
Epidemiologists (CSTE) occupational health indicators (OHI), including the statewide employment profile;
improve data collection for occupational lead exposure, analyze and interpret the resulting data; promote the
importance of collecting work-related variables, such as industry and occupation (I/O); and identify potentially
new sources of data to support total worker health in Pennsylvania. PennOSHS will also develop education
and training materials and other outreach efforts based on the analysis of OHIs to prevent/minimize
occupationally linked morbidity and mortality especially those related to occupational lead exposure. These
efforts will be supported by developing partnerships with a diverse group of occupational safety and health
stakeholders (academic, governmental and community entities) and establishment of an advisory committee
which will guide and monitor program implementation and progress.

Public health relevance
Project Narrative Pennsylvania seeks to establish an Occupational Safety and Health Surveillance (PennOSHS) program filling a much needed gap to collect, analyze, interpret, and disseminate data related to workers and worker health while simultaneously identifying and engaging a diverse group of partners and stakeholders. The ultimate goal of the program is to contribute to reducing occupational morbidity/mortality and occupational health disparities in Pennsylvania. As the fifth most populous state in the nation, PennOSHS will also contribute significantly to the national occupational health surveillance system, especially in the area of work-related lead exposure, as Pennsylvania has one of the highest burdens of elevated adult blood levels in the nation.